Development of a Digital Cognitive Screening Test to detect Mild Cognitive Impairment and Dementia in Clinical Settings.

Project Summary
Alzheimer’s disease and related dementias are a growing health problem in our aging population.
Assessment of cognitive functioning for early detection is critical to identify individuals who might
benefit from treatment with the available symptomatic medications for mild dementia as well as future
disease-modifying therapies that are actively under development and being tested in clinical research
trials. Current cognitive screening tools are time-consuming and not routinely used or documented in
busy primary care settings. As a result, we need easily accessible tools, such as patient self-administered
measures, to screen individuals in primary care settings to guide counseling, referrals, and interventions.
The proposed STTR Phase I project aims to develop and test an innovative digital cognitive screening
instrument, RIMCAT (Rhode Island Mobile Cognitive Assessment Tool) to identify mild cognitive
impairment and dementia in older adults. RIMCAT consists of 10 components and was designed for
self-administration in supervised settings such as primary care practices and provides a cognitive-friendly
interface allowing voice inputs, keyboard typing, and easy-to-understand instructions. The goal of this
STTR project is to examine the initial reliability and validity of RIMCAT through a psychometric study. The
project also includes the development of a digital health framework to support the workflow of
MCI/dementia screening. This supplementary fund is requested to meet the unanticipated needs to
accommodate the additional 40 participants (suggested by reviewers), to prepare remote study sites in
Rhode Island, and to scale the digital health framework.

Public health relevance
Project Narrative This STTR Phase I proposal aims to develop and test an innovative digital cognitive screening instrument, to identify mild cognitive impairment and dementia in older adults. We will conduct a feasibility study to measure the initial reliability and validity of the instrument on 50 cognitively healthy older adults and 50 with cognitive impairment. We will develop a digital health framework to support the administration and scoring of RIMCAT in the current workflow. This supplementary fund is requested to meet the unanticipated needs to accommodate the additional 40 participants (suggested by reviewers), to prepare remote study sites in Rhode Island, and to scale the digital health platform.